Pragmatic randomized trial of polygenic risk scoring for common diseases in primary care

In this project, we will develop and validate clinical polygenic risk scores (PRS) for six common diseases:
coronary artery disease, atrial fibrillation, type 2 diabetes mellitus, breast cancer, colorectal cancer, and
prostate cancer. This test will then be used in a point-of-care pragmatic randomized controlled trial of PRS
testing and linked clinical recommendations compared to usual care (UC). Enrolled patients without a known
diagnosis of any of the six target diseases will undergo clinical PRS genotyping. Patients with at least one PRS
indicating high risk (odds ratio, ORPRS, ≥2.5) will be randomized to have them and their primary care provider
receive their high-PRS results at baseline (PRS arm) or after a 24-month observation period (UC arm),
reported along with evidence-based screening and management recommendations. Patients will be observed
for 24 months for the primary clinical outcome of time-to-diagnosis of any one of the 6 target diseases.
Secondary clinical outcomes will include changes in clinical management and patient health behaviors.
Enrolled patients with all ORPRS<2.5 will be observed as concurrent controls for the same outcomes. Additional
implementation outcomes will be collected over the course of the study, including provider knowledge and
beliefs about PRS, patient activation, medication adherence, and costs.

Public health relevance
This project will develop a laboratory test that can determine an individual’s genetic risk for six common diseases: coronary artery disease, atrial fibrillation, type 2 diabetes mellitus, breast cancer, colorectal cancer, and prostate cancer. This test will be then be used in a clinical trial to identify primary care patients at high genetic risk for at least one of these diseases. This trial will study whether the use of this genetic test helps patients and primary care providers diagnose and treat these diseases earlier. Additional outcomes will be tracked, including the impact of the test on patient health behaviors and healthcare utilization and costs.